ADMIN CORE

Project Summary -Administrative Core
This Administrative Core has been managing the activities of the Seattle MDCRC since May 2014. The Core
will continue to provide oversight, coordinate activities and manage budgetary activities. We will assume
responsibilities for outreach activities, help promote a seminar series in coordination with a Training Core.
The Core will be directed by Jeffrey S. Chamberlain, Ph.D. with assistance from Stephen Tapscott, M.D./Ph.D.
Daily operations of the Core will be handled by Ms. Roberta Miller. The Core will be responsible for overseeing
all activities of this Center. This includes budgetary oversight, ensuring compliance with regulatory
requirements, managing resource and data sharing, coordinating travel, managing progress reports and
facilitating access and interaction with the Resource (Vector) Core. This Administrative Core will also work
closely with the Training Core to facilitate mentoring, seminars, lectures and attendance at meetings and
symposia. Coordination will be aided by a Center Executive Committee composed of the PIs and key
members of each Core and Project. We will also seek advice and critiques from our current Center Advisory
Committee. Integration and oversight will also be facilitated by a Center web site managed by this Core. This
publically accessible web site will promote the Center’s mission with summaries of activities and progress,
provide links to publications and events, advertise opportunities related to training and research, provide a
portal to affiliated lab web sites, and links to contact Center members with questions, requests for
reagent/resources or information on methods and data. The Core will manage monthly Center-wide research
meetings that will focus on recent data, areas of collaborative opportunities, announcements and discussions
of progress. The research meetings will also be integrated with a seminar series for outside speakers. Center
meetings and seminars will also be coordinated with relevant Grand Rounds within our Institutions. These
activities will form part of our Outreach program, including opportunities to visit the Center, meet investigators,
provide speakers at events with patients and advocacy groups & present educational activities at local schools
and science events.